Dominantly Inherited Alzheimer Network

Overall SUMMARY
Dominantly inherited Alzheimer's disease (AD) is an attractive model for study because the responsible
mutations have known biochemical consequences that underlie the pathological basis of the disorder. The
opportunity to determine the sequence of imaging and biomarker changes in asymptomatic gene carriers who
are destined to develop AD may reveal critical information about the pathobiological cascade that culminates in
symptomatic disease. Because the clinical and pathological phenotypes of autosomal dominant AD (ADAD)
appear similar to those for the far more common late onset “sporadic” AD, the nature and sequence of brain
changes in ADAD are relevant for late-onset AD (LOAD). Promising therapeutic agents for ADAD may also
apply to LOAD. However, a longitudinal study of a large cohort of individuals with ADAD required innovative
approaches, as ADAD mutations are rare and families are geographically dispersed worldwide. In its initial
funding period beginning in 2008, the Dominantly Inherited Alzheimer Network (DIAN) established an
international, multicenter registry of individuals (gene carriers and noncarriers; asymptomatic and symptomatic)
who are at risk of carrying a known causative mutation for AD in the amyloid precursor protein (APP), presenilin
1 (PSEN1), or presenilin 2 (PSEN2) genes. Individuals are evaluated upon enrollment in DIAN and longitudinally
thereafter with standard instruments including the Uniform Data Set of the Alzheimer's Disease Centers and
protocols developed by the Alzheimer's Disease Neuroimaging Initiative (ADNI) for structural, functional, amyloid
imaging , biological fluids (blood; CSF), and histopathological examination of cerebral tissue in individuals who
come to autopsy.
DIAN's major hypotheses include: 1) AD biomarker changes in mutation carriers occur many years before
symptomatic AD, supporting the concept of preclinical AD; 2) initial biomarker changes in the preclinical stage
of ADAD will involve Aβ42, followed by neurodegeneration and subsequent cognitive decline; and 3) the clinical
and neuropathological phenotypes of ADAD will be similar to, but not identical with, those of LOAD. Although
cross-sectional data obtained in preceding budget periods provided support for each of these hypotheses, we
are increasingly finding that longitudinal data provides more accurate and precise information on biomarker
changes. Hence, this application emphasizes longitudinal data collection and analyses. This renewal
application continues to address the original DIAN hypotheses and aims, such as maintenance of the
established international DIAN registry of individuals. Importantly, three new scientific initiatives are integrated
to investigate common ADAD mechanisms of Aβ pathogenesis (Project 1), tau pathophysiology (Project 2), and
novel mechanisms of neurodegeneration and neuroinflammation (Project 3). We also propose to harmonize
DIAN with the independently funded DIAN Trials Unit (TU) and Expanded Registry (EXR) to enable data sharing
across all three studies.

Public health relevance
Overall PROJECT NARRATIVE Alone among leading causes of death in the United States, Alzheimer disease (AD) lacks any effective treatment or prevention mechanism. The Dominantly Inherited Alzheimer Network (DIAN) provides a unique opportunity to understand the development of brain changes in AD, even many years before symptoms of the disease appear. Identifying this asymptomatic period also allows intervention with anti-AD drugs in an effort to prevent symptoms from ever occurring, a goal that is highly relevant not only to DIAN but also the far more common “sporadic” form of AD.